Trial of a harm reduction strategy for people with HIV who smoke cigarettes

Project summary. Approximately half of people with HIV (PWH) in the US smoke cigarettes, and the most
optimistic predictions indicate that notwithstanding aggressive anti-smoking efforts, the large majority of these
individuals will continue to smoke. The overall goal is to evaluate the potential of a harm reduction (HR)
strategy to improve the health of a much broader swath of PWH smokers, both those who quit and those who
continue smoking. We will offer all participants an evidence-based, intensive combined behavioral (Positively
Smoke Free on the Web embedded within the BecomeAnEX [EX+] online community) and pharmacologic
cessation treatment followed by a HR intervention in those who are randomized to EX+/HR and treatment as
usual (TAU) in those who are randomized to EX+/TAU. HR will consist of an informational video encouraging
those who have not yet quit to cut down, and patient navigator assisted low-dose CT (LDCT) lung cancer
screening and referral to Cardiometabolic Clinic to optimize blood pressure and lipid management (the latter
two referrals for those who qualify based on age, smoking history, blood pressure, and/or cholesterol
measurements). The specific aims are to (1) complete an RCT comparing these approaches at Montefiore
Medical Center in the Bronx with 400 participants randomized 1:1 to EX+/HR or EX+/TAU with the primary
outcomes of change in (Δ) # cigarettes smoked per day (CPD), % completing LDCT lung cancer screening, Δ
systolic blood pressure, Δ total cholesterol, and Δ American College of Cardiology/American Heart Association
(ACC/AHA) Pooled Cohort Equation score (PCEs) for risk of atherosclerotic cardiovascular disease, and
biochemically confirmed abstinence at 9-months, (2) to perform cost-effectiveness modeling of these two
approaches with projections beyond the horizon of the grant period and estimates for national impact if the
approaches were disseminated to the entirety of the US PWH population, and (3) to complete RE-AIM
analyses of the approaches in order to assess their feasibility, sustainability, and generalizability.
The overarching hypothesis of the research is that the EX+/HR approach will generate significantly greater
advantages in terms of reduced risk for death from lung cancer and cardiovascular disease that translate into
reduced morbidity and mortality when modeled on a macro level.
The project will leverage the long-term collaborations of the Albert Einstein College of Medicine/Montefiore
Medical Center with Truth Initiative, Westat, and the Medical Practice Evaluation Center (MPEC) of the
Massachusetts General Hospital (MGH), which has led the research and public health world in modeling the
effects of behaviors and therapeutic strategies, including tobacco use behaviors and treatments, on the long-
term health of PWH in the US and beyond. They will employ their Cost-Effectiveness of Preventing AIDS
Complications (CEPAC) microsimulation methodology with inputs from our trial and from public-domain
datasets to estimate the effects that our two approaches would have on the PWH smoker population nationally.

Public health relevance
Project Narrative. Cigarette smoking is now the leading killer of people with HIV (PWH) in the US, and most cessation strategies tried to date have failed to increase long-term quit rates. An “all or none” approach to smoking cessation in PWH offers little benefit to the large majority of PWH who are unable or unwilling to quit. In this proposal we argue that a harm reduction approach (i.e. cut down, get screened for lung cancer, control your blood pressure and cholesterol) has the potential to yield significant benefits in terms of the private and public health of PWH in the US.